Structural Studies of RNA Polymerase II Transcription Initiation and Elongation

PROJECT SUMMARY
DNA-directed RNA Polymerase II (Pol II) is one of the most important molecules in biology. Pol II is highly-
conserved among eukaryotic organisms and plays a fundamental role in cellular life; specifically, the
transcription of genes into messenger RNA. Structural studies of Pol II have been very successful and have
allowed snapshots of Pol II in its apo form, in the process of initiation and elongation, during backtracking or
paused by DNA lesions. Moreover, single particle cryo-electron microscopy structures of Pol II in complex
with the general transcription factors (preinitiation complex), and with elongation factors have provided
views of the complexities of the initiation and elongation steps of transcription. A molecular picture of the
role that individual factors play during transcription initiation and elongation is beginning to emerge and has
generated tremendous progress towards our understanding of gene processing and regulation. Conversely,
the molecular details of nucleotide addition and the roles of conformational changes by conserved and
essential domains such as the so called “trigger loop” or “bridge helix” in substrate selection and catalysis
are not fully understood. Furthermore, pioneering studies are at lower resolution and miss critical
information to inform a complete enzymatic mechanism. This project, through extensive technology
development and innovation in structural approaches to Pol II, describes the foundation to reveal the active
site rearrangements within Pol II leading to catalysis and subsequent translocation. The studies proposed
employ a combination of state of the art technologies including time resolved X-ray crystallography, free
electron laser and single particle cryo-electron microscopy experiments to elucidate the time evolution of the
molecular events during Pol II transcriptional elongation. Importantly, orthogonal approaches are developed
to validate results from multiple independent methodologies. The Pol II system represents a model for all
cellular RNA polymerases and results obtained will represent foundational models with which Pol I, Pol III,
and prokaryotic RNA polymerases may be compared. Insight into the Pol II catalytic mechanism and
determination of how activity-altering mutants alter it will provide the framework for understanding ho
regulatory factors that target the Pol II active site might work.

Public health relevance
Project Narrative. DNA-directed RNA Polymerase II (Pol II) is one of the most important molecules in biology. Pol II is highly- conserved among eukaryotic organisms and plays a fundamental role in cellular life; specifically the transcription of genes into messenger RNA. Pol II studies, and RNA polymerase studies in general, lag the diverse and extensive studies on DNA polymerases where high resolution, atomic level data on conformational changes and chemical groups that drive catalysis and translocation have been revealed. Catalysis and translocation of multi-subunit RNA polymerases underlie all cellular RNA synthesis. Advancing our knowledge will be hugely significant for understanding how these enzymes work and are potentially regulated by initiation and elongation factors. Our preliminary experiments reveal “snapshots of the transcriptional process at different time points”. The studies proposed in this renewal will uncover (for the first time) a “molecular movie” of nucleotide addition and will lead to the fundamental understanding of the mechanisms of DNA mediated transcription. We propose to “direct and produce” a movie of Pol II in the act of transcription that will illuminate the intricacies of one of the most fundamental process in biology.